Continuation of the NuMoM2b Heart Health Study

PROJECT SUMMARY/ABSTRACT
Adverse pregnancy outcomes and complications such as preterm birth, preeclampsia,
intrauterine growth restriction, and gestational diabetes present significant risks to pregnant people.
The strongest predictor of these pregnancy outcomes is the occurrence of the outcome during a
prior pregnancy; however, this leaves a large knowledge gap regarding risk prediction for people in
their first pregnancy (nulliparas). To address this gap, the Nulliparous Pregnancy Outcomes Study:
Monitoring Mothers-to-Be (nuMoM2b) enrolled and richly phenotyped a demographically diverse
cohort of women during their first pregnancy. The cohort’s high-quality data and biospecimens were
collected under regulatory frameworks that support resource sharing and data compilation leading
to use in future research. The upcoming public release of nuMoM2b biospecimens requires the
aggregation of biospecimen metadata using a templated spreadsheet provided by NICHD, which
will be completed by the nuMoM2b Heart Health Study team at RTI. The data provided to NICHD
will include all requested fields available in the project data. These data will be provided for the
biospecimens that were originally collected during nuMoM2b and have not yet been analyzed or
earmarked for analysis and a set of aliquots of maternal and fetal DNA that were derived from
nuMoM2b specimens. The Specific Aims reflect an efficient approach to completing advantageous
biospecimen compilation, which can be used in analyses going forward. The RTI team will receive
updated biospecimen inventories from the network partners tracking nuMoM2b biospecimen use
(Aim 1). Once RTI receives information, the nuMoM2b Heart Health Study team will run quality
control checks against the inventory files to ensure accuracy of information and then merge them
with the nuMoM2b data (Aim 2). Upon merging, data will then be exported in the available
biospecimen metadata fields in the requested format (Aim 3). Throughout the process, the team will
also provide support for administration of the funds to support this work. With a foundation of strong
leadership and technical infrastructure, RTI will provide an ideal setting for compiling nuMoM2b
data to continue addressing critical knowledge gaps in the field.

Public health relevance
PROJECT NARRATIVE Pregnancy complications such as preterm birth, high blood pressure during pregnancy, and gestational diabetes are significant health risks for pregnant people. The Nulliparous Pregnancy Outcomes Study: Monitoring Mothers-to-Be (nuMoM2b) enrolled more than 10,000 pregnant people during their first pregnancy to learn more about risk factors for these pregnancy complications, and biospecimens from nuMoM2b will soon be made available to other approved researchers. To support additional research into pregnancy outcome risk prediction and prevention strategies, we propose to compile and aggregate data about the biospecimens as requested and specified by NICHD.